Analysis Core

The overall goal of the Analysis Core (AnC) is to provide the JHAD-RCMAR with the methodologic expertise
needed to create the next generation of research on AD/ADRD, minority aging, and health disparities. Building
on our world-class biostatistics environment at Johns Hopkins, we have expanded our methodological
expertise to include mixed methods and qualitative approaches to better encompass translational studies (e.g.,
intervention development) and implementation research, as well as observational studies of risk factors and
functional and cognitive trajectories. While quantitative approaches can characterize and measure outcomes,
the use of mixed methods and qualitative approaches can complement statistical analyses to identify
unmeasured factors that might be associated with how an individual responds to interventions or to how to
better accommodate diverse needs and circumstances through tailoring interventions. Under the direction of
the Leadership and Administrative Core (LAC), and in close collaboration with the Research Education
Component (REC) and the Community-Liaison and Recruitment Core (CLRC), the AnC aims to provide
methodological expertise in support of the conceptualization, design, implementation, analysis, and
interpretation of research relevant to the work of the RCMAR Scientists; provide access to modern data
acquisition and management tools and emerging computing technologies by capitalizing on the existing IT
infrastructure at the Johns Hopkins Center on Aging and Health; and provide mentoring to junior faculty
supported by the REC, with the goals of maximizing their skills in study design, data analysis, effective
communication with consultants, and ability to translate research findings into clinical and community-based
interventions and practice. The AnC will also provide scientific leadership for the JHAD-RCMAR and heighten
visibility of our research by building and maintaining the JHAD-RCMAR website; disseminate measures,
methods, and findings to the national RCMAR and AD-RCMAR networks and other investigators, and partner
with the CLRC and Johns Hopkins OAIC to increase study recruitment and retention of older adults from
under-represented backgrounds. We have a critical mass of dedicated expertise, infrastructure, and staffing to
support the proposed studies in our AD-RCMAR. The interdisciplinary relationships that we have built with the
gerontologic scientists at Johns Hopkins through years of collaboration in gerontology, and our track record of
employing and teaching state-of-the-art methods, position this Core to make substantial contributions to
minority aging research and the effectiveness of this AD-RCMAR.